Investigating High-Risk Epigenetic Modifying Alterations on JAK2VF Dependency and Fibrotic Progression in Myeloproliferative Neoplasms (MPNs)

PROJECT SUMMARY/ABSTRACT
Myeloproliferative Neoplasms (MPNs) are chronic, progressive hematopoietic disorders characterized by
aberrant proliferation of myeloid lineage constituents, pro-inflammatory sequelae, progressive bone marrow
fibrosis, and increased risk of leukemic transformation. Gain-of-function mutations of the JAK/STAT pathway,
including JAK2VF, are present in the majority of MPN patients and are amenable to targeted inhibition; however,
clinically-improved JAK2 inhibitors fail to reduce mutant allele burden, and response wanes over time. Somatic
alterations in high-risk chromatin modifiers ASXL1 and EZH2 co-occur frequently with JAK2VF in MPN and confer
adverse prognosis, myelofibrotic progression, and reduced response to JAK2 therapy. The mechanisms by
which chromatin dysregulation secondary to ASXL1/EZH2 alterations enhance clonal evolution and pro-fibrotic
inflammatory pathways to promote fibrosis progression and JAK2 inhibitor resistance have not been elucidated.
Recently, we demonstrate an absolute requirement for mutant Jak2VF in MPN maintenance using a dual-
recombinase knock-in/knock-out mouse model of Jak2VF. I hypothesize that Jak2VF cooperates with Asxl1 or
Ezh2 loss to alter dependency on JAK/STAT signaling for disease maintenance and promote pro-inflammatory
signaling pathways favoring fibrotic progression. In this proposal, I will investigate the requirement for oncogenic
Jak2VF signaling and reversibility of epigenetic dysregulation and pro-inflammatory mediated fibrosis/niche
remodeling in high-risk dual-mutant MPN using my dual-recombinase Jak2VF allele. I will complement this with
single-cell DNA sequencing + immunophenotyping/cytokine analysis of clinical MPN specimens evaluating
cytokine production, clonal evolution, and order of mutation acquisition in MF progression. Further understanding
of the cooperative effects of chromatin dysregulation in fibrotic progression and therapeutic resistance in MPNs
might lead to the identification of therapeutically tractable dependencies for this high-risk MPN patient subset.
Andrew Dunbar, MD, an Assistant Attending at MSKCC, will conduct this project as part of a 5-year career
development plan, dedicating >75% of his time to research with remainder on clinical work. Dr. Dunbar is
mentored by Dr. Ross Levine, a world expert in the study of hematologic malignancies. Dr. Dunbar is advised
by Drs. Raajit Rampal, Omar Abdel-Wahab, Richard Koche and Andriy Derkach at MSKCC, Dr. P. Brent Ferrell
at Vanderbilt University Medical Center, and Dr. Rebekka Schneider at University Hospital RWTH Aachen,
Germany. Andrew’s training will include gaining technical skills in performing and analyzing single-cell genotypic
assays with formal courses in bioinformatics, modeling the bone marrow microenvironment, and methods to
investigate the epigenetic regulation of hematopoietic stem cells. In the short term, the project goal is to publish
two papers on the findings from this research. In the long term, the goal is for developing a research program
and obtaining R01 funding to become an independent laboratory investigator in hematologic malignancies.

Public health relevance
PROJECT NARRATIVE High-risk molecular mutations in the epigenetic regulators ASXL1 and EZH2 co-occur frequently with JAK2V617F activating mutations in myeloproliferative neoplasms (MPNs) and portend risk of fibrotic progression, shortened duration of response to targeted JAK inhibitor therapy, and increased rate of leukemic transformation. We hypothesize ASXL1/EZH2 mutations cooperate with JAK2V617F to enhance clonal fitness/outgrowth of mutant hematopoietic stem cells and pro-fibrotic inflammatory signaling pathways to impart resistance to JAK inhibitors and promote fibrotic alterations in the bone marrow niche. Our work aims to utilize an optimized inducible and reversible Jak2V617F mutant mouse model, a large cohort of banked MPN patient samples, and an array of in vivo and genomic/epigenomic techniques to understand how epigenetic alterations contribute to clonal/fibrosis evolution in MPNs with the goal of translating our findings into novel therapeutic avenues for MPN patients with high-risk epigenetic alterations.